Fatty Acid Metabolic Regulation of Anti-Tumor Immunity Against Irradiated Glioblastoma

PROJECT SUMMARY
Glioblastoma (GBM) is a devastating brain tumor disease with a median overall survival of approximately 15
months. GBM patients die because of the constant ability of GBM to acquire resistance mechanisms against
anti-cancer therapies, therefore leading to an inevitable tumor recurrence.
Radiation therapy (RT) is a pivotal modality for improving overall survival of GBM. However, GBM invariably
recurs, which suggests that RT is eliciting or exacerbating mechanisms of resistance in GBM. Identifying and
overcoming the contributing factors involved in GBM resistance is a major challenge in Radiation
Oncology. GBM metabolism and its role in immune evasion emerges as a RT-induced resistance mechanism
in GBM. Specifically, we have preliminary data indicating that irradiated GBM cells reprogram their metabolism
towards the generation of fatty acids. Such metabolic reprogramming after RT is impairing the innate immune
recognition and systemic anti-tumor immunity elicited by RT. More precisely, we have preliminary evidence that
fatty acid synthesis is inhibiting nucleic acid sensing-dependent interferon type I (IFN-I) responses and is
promoting immunosuppressive signals such as the programmed-death-1 (PD-1) and the programmed-death
ligand 1 (PD-L1). As a consequence, cancer cell-intrinsic IFN-I will not be released in response to RT. This
ultimately limits anti-tumor immune response against GBM by precluding infiltration effector T cells into the GBM
microenvironment. We have recently demonstrated that cancer cell-intrinsic IFN-I response is an essential step
to convey immunogenicity of an irradiated tumor. Consequently, by increasing energy supply, limiting innate
immunity and increasing immunosuppression, RT-induced fatty acid synthesis is likely to be a major GBM
resistance mechanism that not only impacts RT response of GBM but also provides means to evade immune
recognition. In this application, we propose to test the novel and innovative hypothesis that fatty acid
metabolism induced by RT controls immune escape and GBM survival. Successful completion of this
proposal will define how fatty acid synthesis facilitates GBM immune evasion and provide pre-clinical
evidence for fatty acid inhibitors as a novel approach to restore the immunogenicity of irradiated GBM.

Public health relevance
PROJECT NARRATIVE Radiation therapy reprograms the metabolism of glioblastoma (GBM) towards the synthesis of fatty acids. Our proposed studies aim to define the consequences of such metabolic shift on the immunogenicity of irradiated GBM. Our ultimate goal is to shed light on a novel actionable target to restore brain immunity and stop GBM recurrence in the context of RT.